PATHOPHYSIOLOGY, PHARMACOLOGY, AND TREATMENT OF ORTHOSTATIC TACHYCARDIA

The overall goal of this project is to test the hypothesis that partial dysautomonia is the underlying pathophysiology for a significant portion of patients with orthostatic tachycardia. A secondary goal is to find effective treatment for this syndrome.